Administrative Core

Administrative Core - Summary
The Administrative (Admin) Core serves as the central resource of the Columbia University Northern Plains
Superfund Research Program (CUNP-SRP). CUNP-SRP is a new center that will establish a partnership
between scientists and tribal communities to advance science and technology to address hazardous chemicals
in drinking water and their related health effects in the Northern Plains. It will be led by Dr. Ana Navas-Acien, a
physician-scientist and environmental epidemiologist who has been working with tribal communities for more
than a decade, and Dr. Steven Chillrud, an environmental geochemist with longstanding experience in exposure
sciences, remediation of Superfund sites, and research translation. Our Tribal Communication Specialist will be
Rae O’Leary, a public health expert centrally located at the Cheyenne River Sioux Tribe in the Northern Plains
with experience in policy development working with tribal leadership. The CUNP-SRP Admin Core’s main
objective is to facilitate the interaction and success of each Project and Core and to maximize the impact of all
its activities, including translation and communication with our tribal partners in the Northern Plains, in
collaboration with the Community Engagement Core. The Admin Core will support research translation of CUNP-
SRP activities by: a) partnering with tribal and governmental agencies to promote and facilitate water testing,
connect houses on wells to community water systems, and educate communities on legislative options;
b) coordinating technology transfer including local commercialization of research designs developed by CUNP-
SRP investigators; c) communicating within SRP and to NIEHS SRP staff results of those translation activities
as well as findings from Projects/Cores; d) fostering and reporting investigator-initiated research translation; and
e) providing information dissemination to other end-users. The specific aims are as follows: (1) Foster
interdisciplinary collaboration through collective leadership and strategic vision and coordination of seminars/
webinars, meetings (including the monthly steering committee meeting and the monthly research seminar),
annual progress reports, evaluations, and other activities; (2) Enable multidirectional research translation
among investigators, NIEHS, other SRPs, tribal, state, and federal government agencies, other organizations,
community partners, and the broader public; and (3) Facilitate career development of early-stage scientists,
including Native American investigators, through mentoring and networking activities and the support of
applications in response to program announcements, awards, and diversity supplements. Overall, the Admin
Core will promote integration of Projects and Cores to inform the CUNP-SRP on the best methods and strategies
to reduce hazardous water contaminants (with a focus on metals), facilitate remediation in contaminated
Superfund sites and tribal lands, and mitigate the health effects of water contamination long-term.

Public health relevance
Administrative Core - Narrative The Administrative Core serves as the central resource of the Columbia University Northern Plains Superfund Research Program (CUNP-SRP), a new center that will establish a partnership between scientists and tribal communities to advance science and technology to address groundwater contaminants and their related health effects in the Northern Plains. The Core will foster interdisciplinary collaboration, promote research translation, and facilitate career development of early-stage investigators, together ensuring that activities of the CUNP-SRP are both relevant and impactful. The Administrative Core will integrate Projects and Cores to ensure that the CUNP-SRP contributes to effective strategies to monitor water contaminants, facilitate their remediation, and mitigate their health effects in the target communities, at other contaminated Superfund sites, and for other at- risk populations.